Clinical Image Processing Service

During the past year, CIPS completed 1000's of clinical orders. The members in CIPS published 25 papers in journals and conferences through our research collaborations. We began a few new image processing services. We improved our tumor measurement procedure. We also developed an accumulative tumor reporting system to integrate CIPS workstations with PACS and RIS system. We devised a framework to output results from commercial workstations for further analysis. CIPS is developing technologies to incorporate computer-aided detection and measurement analyses on radiology scans into the PACS using full automation to improve daily patient care. We are developing software to perform real-time monitoring of patient radiation exposure from CT scanning to ensure that the lowest effective radiation dose is used.